Preclinical Assessment Tools for Preventing Fretting-Corrosion within Modular Junctions of Total Joint Replacement

Fretting-corrosion in total joint arthroplasty (TJA) modular junctions can lead to implant failure and adverse
local tissue reactions (ALTRs). ALTRs—mainly caused by fretting-corrosion products—can lead to catastrophic
failures with a 3 to 5% prevalence in total hip arthroplasty. There is a large body of fretting-corrosion literature
dating back to the 1980s. However, the rise in fretting-corrosion complications tells us that not all mechanisms
of fretting-corrosion in modern TJA are known and that preclinical tests cannot predict when fretting-corrosion
occurs in new designs. Thus, four critical barriers remain. 1) An incomplete understanding of the actual failure
processes leading to ALTR; 2) Misleading preclinical testing strategies that do not consider the biological
environment including inflammatory cells that can cause cell accelerated corrosion (CAC); 3) Insufficient
material standards that do not eliminate microstructural preferential corrosion sites; 4) Neglecting surface
topography in in vitro and in silico tests. The long-term goal is to increase TJA longevity by eliminating fretting-
corrosion-induced ALTRs. Thus, this study aims to create comprehensive preclinical testing strategies and
further elucidate the factors contributing to in vivo fretting-corrosion damage and ALTR in TJA. The central
hypothesis is that the onset and progression of fretting-corrosion and ALTRs are 1) dependent on macro- and
micro-surface geometry, manufacturing tolerances, and alloy microstructure, and 2) can be pre-clinically
predicted by a combination of multi-scale finite element analysis (FEA), partial-slip fretting and corrosion tests
under CAC conditions, and characterization of alloy microstructure to identify preferential corrosion sites. We
will test our central hypothesis with three aims. Specific Aim 1: Identify factors dictating fretting onset and
progression in primary TJA surgery and revision surgical interventions (ceramic heads and sleeves and dual
mobility constructs). Specific Aim 2: Determine how implant design, bulk material, and alloy microstructure can
enable indirect and direct cell accelerated corrosion (CAC) in modular junctions. Specific Aim 3: Determine
how implant alloy microstructure can minimize the risk of material loss and ALTR under progressing fretting-
corrosion and simulated CAC conditions. We will integrate the results from these individual studies to
determine the total risk for ALTR by analyzing the 1) immune cell response within ALTR in periprosthetic
tissues, 2) damage modes on the implant surfaces corresponding to the periprosthetic tissues, and 3) inputs to
FEA and in vitro tests that are associated with these damage modes. The approach of retrieval analysis, finite
element analysis, alloy characterization, fretting/corrosion tests, histopathology, and cell culture testing will
lead to a better understanding of this significant clinical problem, better preclinical testing strategies, and
implant alloy characterization protocols/specifications. The proposed work is innovative because these new
tools will enable the improvement of scientific knowledge, technical preclinical testing capabilities, implant
material standards, and clinical practice for predicting and monitoring fretting-corrosion and risk of ALTR.

Public health relevance
The proposed research is relevant to public health because adverse local tissue reactions to implant debris generated under fretting-corrosion within total joint modular junctions is a current clinical issue affecting many patients. This research will help reduce total joint arthroplasty failures, and ultimately help delay or avoid revision surgeries that are risky for the patient, technically difficult for the surgeon, and expensive. Therefore, the proposed research is relevant to the NIH mission by 1) reducing the burden of human disability by improving the quality of life of total joint arthroplasty patients and 2) reducing the cost of medical care by preventing revision surgery.